Transcriptomic Core

PROJECT SUMMARY
The Single Cell Analysis and Bioinformatics Core will provide state-of-the-art experimental technology,
computational biology, and biostatistical support tailored specifically to the program project. This includes
scalable, pooled-sample methodology for single-cell RNA-seq (scRNA-seq) and multi-modal single-cell analysis
technologies for multiplexed lineage tracing and surface protein profiling (CITE-seq). The Core will also provide
comprehensive bioinformatics support including data processing and specialized tools for dimensionality
reduction and automated annotation of single-cell data. Finally, we will assist Project investigators with
experimental design and statistical modeling across a variety of modalities including single-cell genomics, mass
spectrometry, and indirect calorimetry.